Training in Methods of Computational Neuroscience (MCN)

ABSTRACT
The Methods in Computational Neuroscience (MCN) course at the Marine Biological Laboratory in Woods
Hole, MA provides a unique training opportunity to equip students with cutting edge skills and conceptual
foundations of computational methods to understanding the biological function and neural mechanisms of brain
cells, circuits, and behavior. MCN is an intense lecture and computer laboratory course targeted to a talented
mix of students with complementary expertise in biological and mathematical sciences. MCN students interact
one-on-one with internationally renowned scientists and carry out hands-on, project-based training with a wide
variety of computational techniques and approaches. The goals of the MCN course are to train students 1)
in the concepts and methods of computational approaches to understanding brain function 2) in the
mathematical foundations and techniques for the analysis of neural data 3) to use computational tools
to solve fundamental questions in neurobiology, 4) to use computational methods to diagnose and
treat human brain disorders and 5) to foster interdisciplinary collaborations that lead to long term
interactions and mentorship. The course provides in-depth instruction on how to use computational
approaches to solve fundamental problems in neurobiology using experimental techniques applied across a
wide range of biological scales from molecules to behavior. This is accomplished through hands-on training in
the mathematical foundations and techniques for the model-based, statistical and theoretical analysis of neural
data in the context of mechanistic descriptions of neurons, networks, and brain systems. The MCN course
continually updates its computational topics that are relevant to new experimental advances, such anatomical
connectivity at microstructural and brain-wide scales, high density measurements using electrical and optical
recording, and causal perturbations of neural circuits using optogenetics. These new topics include state-space
trajectory analysis, deep networks, compressed sensing, advanced statistical inference, manifold learning,
dimensionality reduction, analysis of large data sets including brain wide imaging and large scale cell-type
specific connectivity. An additional innovation is an increased emphasis on computational approaches to
understanding and addressing brain disorders, including the emerging field of computational psychiatry.
Central to the course is an environment of intense interactions with a group of dedicated faculty, many of
whom devote weeks or even the entire month to work with students. In the last half of the course students
devote concentrated effort to novel cutting edge research projects mentored by a team of faculty and teaching
assistants. The course fosters a collegial, international environment that advances student careers by
providing students with networking opportunities that lead to long-term interactions, mentorship, and
collaborations.

Public health relevance
PROJECT NARRATIVE Advanced computational approaches are required to understand the complexity of the nervous system and to treat neural diseases. The Methods in Computational Neuroscience Course (MCN) provides a unique training environment that gives trainees a set of cutting-edge computational tools to analyze the explosion of neural data emerging from advanced experimental techniques, and to build powerful computer models of brain circuits. These concepts, tools and techniques will train a new generation of experimentalists and theorists to understand brain function and to treat brain disorders, including schizophrenia, epilepsy, addiction, depression, and Parkinson’s disease, as well as a new component explicitly dedicated to computational psychiatry, a nascent field bridging computational neuroscience and mental health. !